GENETICALLY ENHANCED ANGIOACCESS VASCULAR GRAFTS

Thrombin is postulated to mediate neointimal vascular lesion formation at sites of denuding vascular injury. This hypothesis has been tested in baboons by measuring the effects of hirudin, a potent direct antithrombin, on the formation of vascular lesions induced by implanting arteriovenous vascular grafts (AVGs). Hirudin was delivered locally into the blood flow boundary layer by retroviral-transduced hirudin-secreting vascular endothelial cells (ECs) covering AVG luminal surfaces. Measurements of neointimal lesion formation at distal graft-vascular anastomoses were compared for AVG-ECs that had been transduced with a retroviral construct containing a cDNA encoding hirudin vs non-hirudin control ECs. Stable hirudin-secreting transduced-ECs were established in cell culture. Antithrombotic efficacy of EC-secreted hirudin was demonstrated for thrombogenic segments interposed in chronic exteriorized femoral arteriovenous (AV) shunts. AVG flow surfaces were endothelialized by a ttaching hirudin-transduced vs non-hirudin control ECs at confluent density in vitro. EC-lined AVGs were surgically implanted in baboons as bilateral brachial AVGs, one covered with non-hirudin control ECs, and the contralateral AVG covered with hirudin-secreting ECs. Hirudin-secreting ECs decreased thrombus formation on segments of collagen-coated graft interposed in chronic AV shunts. Hirudin-secreting ECs also reduced platelet deposition in propagated thrombotic tails extending downstream from segments of vascular graft. Thus, hirudin-transduced ECs produced levels of hirudin locally that decreased thrombin receptor- (TR)-dependent platelet deposition without compromising hemostasis systemically. ECs covering luminal flow surfaces of implanted AVGs remained attached throughout the 30-day period, as shown by initial imaging studies of attached 111In-EC following AVG implantation, subsequent scanning electron microscopy, and by recovery of hirudin secreting ECs from 30-d AVG implan ts that generated 17"7 (range 9-25) ng/106cells/24 hr hirudin. AVGs covered with hirudin-secreting ECs reduced neointimal lesion formation at distal graft-vessel anastomoses, i.e., 1.02 " 0.14 mm2 vs 1.82 " 0.15 mm2 in contralateral AVGs bearing non-hirudin control ECs (p <0.01). As anticipated, ipsilateral upstream arterial-AVG anastomotic lesion formation was not significantly decreased, i.e., 1.26 " 0.92 mm2 vs 1.99 " 0.86 mm2 (p>0.1). Viral vector-directed secretion of hirudin from ECs lining implanted AVGs significantly reduces neotintimal vascular lesion formation, indicating the importance of thrombin in the production of neointimal proliferative lesions.